Dissecting and connecting the SigM stimulus and ESX-4 secretory response in mycobacteria

Mycobacteria utilize Type VII (ESX) secretion systems to export substrates across their complex cell envelope.
Mycobacteria encode multiple paralogous ESX systems (M. tuberculosis encodes five ESX systems), which
have evolved to perform non-redundant functions. Despite almost two decades of research, only ESX-1, -3 and
-5 have been characterized and assigned functions in virulence, iron-uptake and cell wall integrity,
respectively. The lack of a comprehensive understanding of the roles of ESX systems, their substrates and
extracellular targets represents a significant gap in our understanding of mycobacterial biology.
In this proposal, we will focus on ESX-4, which is considered the progenitor ESX secretion system because it
is found in all mycobacteria. The absence of esx4 locus gene expression had confounded previous ESX-4
analyses and prevented its functional characterization. However, we demonstrated ESX-4 expression is
triggered by direct cell-cell contact, which activates the extra-cytoplasmic sigma factor, SigM, to initiate
transcription of the conserved core esx4 genes. Our data also show that SigM is dedicated to the regulation of
an extended ESX-4-gene set, many of which are conserved in other mycobacterial species and are also
controlled by SigM. The ability to directly control ESX-4 expression via SigM provides a unique opportunity to
study the role of ESX-4 in both fast- and slow-growing mycobacteria.
We have demonstrated ESX-4 is essential for conjugal DNA transfer in M. smegmatis and that ESX-4 induces
changes in gross colony morphology and cell wall composition. In M. abscessus, ESX-4 plays a direct role in
pathogenesis: it is required for intracellular survival in macrophages and amoebae, blocks phagosome
acidification and promotes phagosomal rupture in infected macrophages. By extension, we hypothesize ESX-4
plays an important role in other pathogenic mycobacteria, mediated by ESX-4 secretion of effector molecules
and remodeling of the cell wall. In this proposal, we will compare and contrast the ESX-4 systems of M.
tuberculosis, M. marinum, M. abscessus and M. smegmatis, utilizing the ability to activate ESX-4 by SigM.
Using a combination of biochemical, chemical biology, genetic, and molecular techniques we will define the
SigM regulon and ESX-4 secretomes of each species. We anticipate identifying effector molecules that
facilitate remodeling of the mycobacterial cell wall, as well as those that target other bacteria or the host
macrophage. Together, this work will provide the first comprehensive analysis of ESX-4 and, importantly,
significant new insights on the conserved and species-specific functions of this ancestral secretion apparatus.

Public health relevance
Project narrative. Mycobacterial diseases place a huge burden on global public health. There is a need to understand the biology and pathogenesis of mycobacteria. In this proposal, we will characterize a highly conserved mycobacterial secretion system, called ESX-4, and determine its role in the biology and pathogenesis of four scientifically important mycobacterial species.